Howard University Research Center for Minority Health and Health Disparities

Title: Comparing Engagement Modalities for Persons high-risk for HIV or with HIV Abstract The Department of Health and Human Services has set a goal of stopping the HIV epidemic by cutting new cases by 75% by 2025 and 90% by 2030. Substantial multiagency resources have been expended towards this goal. These resources include research, direct services, reimbursement to providers and education. Explicitly, efforts are underway to decrease transmission by encouraging safe sex, harm reduction methods related to substance use, introduction and maintenance of PrEP and treatment with antiretroviral medication. The effort has targeted certain geographic regions that have been shown to be particularly affected. There has been some success in these efforts. However, the onset of our new epidemic, Covid-19, has limited progress and in some areas even resulted in regression. Barriers to care have arisen because of limitations in going to the office, decreased community outreach, the proliferation of misinformation and increased concerns related to the social determinants of health. The purpose of this proposal is to design, implement and evaluate an intervention of case management services to bring those who are at high risk for HIV and those who already have HIV into care with the goal of preventing infection with HIV or, if already infected, start and maintain treatment. The model will be community centric. By this it is meant to emphasize community outreach in the form of the team having a presence in the community?s that are being targeted, collaborating with community organizations that are already working with these populations and expanding service availability. Outcomes for this project will be participants who are getting tested, participants started on PrEP, maintenance of PrEP, participants started on treatment, and maintenance of that treatment. Additionally, social determinants of health that may impact on the above outcomes will be assessed. 1

Public health relevance
Title: Comparing Engagement Modalities for Persons High-Risk for HIV or with HIV Project Narrative Research has shown that case management can be effective in improving HIV outcomes via the initiation and maintenance of therapy either for prevention or treatment. Likewise, peer support has been helpful. Finally, there have been projects that use electronic communication to transmit educational messages. These three options can be considered part of a menu of “best practices.” The common point in each of these is that they all provide actionable education to the targeted populations. This project will measure the relative effectiveness of each and study the relative impact of any combinations of the three. Finally, this study will give initial data that would be able to predict which of the three would be most effective in an individual patient based on certain characteristics. 1